Role of the MIF/CD74 pathway in ILC2-driven airway hyperreactivity

PROJECT SUMMARY
The long-term goal of this study is to increase our understanding of the immune mechanisms involved
in the pathogenesis of allergic disease and asthma. Despite the identification of elevated Macrophage migration
inhibitory factor (MIF) levels in asthmatic patients, the contribution of MIF to the pathogenesis of asthma remains
elusive due in parts to the considerable heterogeneity of asthma endotypes and lack of mechanistic insights on
the signaling of MIF in immune cells. Group 2 innate lymphoid cells (ILC2) are innate lymphocytes crucial in
asthma, with their activation influenced by various external factors, including cytokines. Our pilot studies using
acute and chronic allergen-induced models of airway hyperreactivity (AHR) show that MIF is induced in the lungs
during inflammation, with activated lung ILC2s rapidly upregulating MIF receptor CD74. Our protein and
transcriptomic analysis further suggest that MIF induces higher ILC2 activation, expansion and metabolic activity
in the lungs through receptor CD74. Understanding how MIF controls ILC2 function can therefore provide a
molecular and cellular framework for appropriate therapeutic approaches to target the pathophysiological root of
asthma rather than symptom relief, meeting the pressing demand for innovative, mechanism-based therapies.
Based on existing evidence and preliminary data, we hypothesize that the modulation of the MIF/CD74
axis in ILC2s has the potential to reprogram the intrinsic metabolic activities of ILC2s. This, in turn, could directly
influence cellular function and contribute to the subsequent development of AHR. In the first part, we will identify
the role of MIF on ILC2 function. Aim 1 will assess the expression patterns of CD74 in the lungs and measure
the effects of MIF or CD74 inhibition on ILC2 activation and development of AHR in different in vivo acute and
chronic models of AHR where a pathogenic role for ILC2s is well described. The role of MIF on ILC2 metabolism
will be characterized in the second part. Aim 2 will analyze how MIF affects ILC2 metabolic pathways fueling
the activity of the mitochondria and provide potential metabolic approaches for the modulation of ILC2 activity.
The proposed studies are conceptually and technically innovative because we will be the first to test the
effects of the MIF/CD74 pathway in ILC2-driven AHR and lung inflammation. In particular, our comprehensive
combined cellular, molecular and metabolism approach utilizing 3 different MIF/CD74 inhibitors and genetically
modified mice was not addressed in any other immune cell population. Our studies will therefore provide pre-
clinical novel data on a previously unrecognized role of this pathway in ILC2 regulation. To conduct these studies,
we have assembled an outstanding team including experts in the fields of asthma and immunometabolism, as
the two aims of the project come together to address the mechanisms through which MIF regulates ILC2-driven
immune responses. Overall, the proposed project therefore holds the promise of uncovering new regulatory
mechanisms in ILC2s that could significantly advance our understanding of the immunomodulatory mechanisms
driving the magnitude of lung inflammation and offer therapeutic options for allergic diseases like asthma.

Public health relevance
PROJECT NARRATIVE This project aims to investigate the impact of the cytokine MIF and relevant signaling through CD74 on cellular and metabolic mechanisms that control inflammation in response to allergens. The objective is to gain a comprehensive understanding of how these factors contribute to lung inflammation, with the ultimate goal of proposing innovative mechanistic-based approaches to target the pathophysiological root of asthma.